Multi-Component Behavioral Activation, Nutrition, and Activity Intervention for Persons Aging with HIV

Summary
This administrative supplement will test the feasibility and acceptability of a brief (12 week) individualized,
Behavioral Activation program focused on decreasing loneliness and increasing social engagement, that will
be augmented with a program to increase home exercise and address poor nutrition among persons aging with
HIV. It will be delivered by remote coaches. Recruitment will include those ages 50+ with HIV from the UM
THRIVE program and other HIV centers in Baltimore as necessary. This work will be accomplished in three
stages: Stage 1: We will start with community engagement strategies, such as focus groups with persons
aging with a HIV diagnosis and clinical providers, to tailor the intervention. A community engagement team will
provide feedback on preferences for delivery mode (telephone, tablet, home, and/or at a community center),
recruitment strategies and brochures, measures, other study materials, inclusion of the physical activity and
nutrition modules. Stage 2: We will work with HIV clinical and research experts in exercise, nutrition, and
psychological functioning to tailor the content of the material and resources for the remote coaches in order to
meet the needs of PAWH. Stage 3: Following the community engagement and tailoring the intervention for
PAWH, we will pilot test feasibility acceptability with 10 persons ages 50+ living with a HIV diagnosis. This
study will test the feasibility of a much-needed intervention to improve functioning and health outcomes among
a vulnerable group of older adults. It is a single-group unblinded feasibility study to explore a new intervention
to support older people aging with HIV. If this intervention appears to be feasible, acceptable, and to show
preliminary evidence of efficacy, we will look be to evaluate it in a phase III efficacy trial. It fits into the scope of
the UM-OAIC, which aims to conduct research on the mechanisms that underly the functional impairments
associated with prevalent chronic diseases in older people; design novel, efficacious rehabilitation
interventions; and translate interventions for implementation and rigorous evaluation outside the clinic (e.g.,
home, senior center, gym).

Public health relevance
Narrative This administrative supplement will look at whether a behavioral intervention to help persons ages 50 and older who are living with a HIV diagnosis. The intervention will involve a person talking with participants and coaching them to be more active, to help decrease loneliness, to exercise more, and eat healthier.